Understanding linguistic differences in mild cognitive impairment: The importance of language context and psychosocial functioning

PROJECT SUMMARY/ABSTRACT
There is great interest in the early detection of amnestic mild cognitive impairment (aMCI) in older adults,
as this stage often precedes dementia due to Alzheimer’s disease. Early identification provides an opportunity
to intervene on modifiable risk factors to slow further cognitive and functional impairment. While behavioral and
psychosocial interventions may effectively delay cognitive decline (e.g., cognitive rehabilitation, physical activity,
psychotherapy), no interventions have specifically targeted the language abilities of older adults with aMCI. This
is a missed opportunity because (1) language impairments may precede impairments in other cognitive domains,
making language metrics potentially more sensitive for detecting aMCI. Previous research has shown measures
of semantic richness (e.g., number of unique words) can differentiate individuals with MCI from cognitively
unimpaired (CU) older adults. (2) Language impairments in older adults may lead to decreased participation in
daily activities, including those that are cognitively protective, such as social engagement. For example,
individuals with aMCI may become socially disengaged due to word-finding difficulties (e.g., they feel
embarrassed about forgetting names, and attend fewer social or work functions). This proposal aims to better
understand the language abilities (i.e., semantic richness) of older adults with aMCI across different
contexts and its relationship with psychosocial functioning. The long-term goal of this line of research
is to design interventions to improve or maintain independence in daily function and slow the onset to
dementia for adults at risk.
Legacy performance-based language tasks (e.g., naming line-drawn objects) are decontextualized and
may not optimally capture the early semantic language changes in aMCI. In contrast, discourse (i.e., connected
speech/language) tasks more closely resemble everyday language use and involve a more complex interplay
between multiple cognitive domains and context demands. This study will leverage the large, open-access
Delaware Corpus of DementiaBank, housed in the established TalkBank system, to address the research aims.
Aim 1 will determine if discourse context (i.e., picture description; story narrative; procedural discourse;
personal narrative) differentially affects semantic richness in aMCI and CU groups. Aim 2 will determine if there
is a relationship between psychosocial functioning and semantic richness in older adults.
Results from this proposal will offer critical insight into the semantic language abilities of individuals with
aMCI across different contexts and its link to psychosocial functioning. This knowledge is essential for developing
effective treatments for individuals with aMCI that target language and psychosocial function (e.g., group
treatment of word-finding problems). The long-term goal of this work is to reduce the functional consequences
of language impairments in aMCI, thereby supporting independence and delaying the progression to dementia.

Public health relevance
PROJECT NARRATIVE The language abilities of people with mild cognitive impairment (MCI), a transitional phase between normal aging and dementia, are often impaired and can affect their participation in daily activities. This study aims to understand the language abilities of older adults with MCI across different linguistic contexts and the relationship between language and psychosocial functioning. Completion of this study will inform the development of a language intervention that could be promptly delivered to people with MCI to reduce the functional consequences of language impairments and help maintain independence.